Molecular pathogenesis of congenital heart disease mediated by neural crest and second heart field cells

ABSTRACT
The cardiac outflow tract (OFT) with adjoining major arteries is susceptible to developmental
insults during embryogenesis that leads to congenital heart disease. Part of the reason for their
vulnerability is because the morphogenesis of the OFT requires the interaction of both neural
crest cells (NCCs) and adjacent second heart field (SHF) mesoderm cells. This takes place
during dynamic expansion of the embryonic pharyngeal apparatus. To understand these two
juxtaposed populations, we performed single cell RNA-sequencing (scRNA-seq) after lineage
purification, focusing mainly on NCCs. Cardiac NCCs (CNCCs) have traditionally been defined
positionally rather than molecularly by specific gene markers of cell fate progression because of
their multipotency and changing genetic profiles. Using scRNA-seq, we were able to identify
putative CNCCs in the pharyngeal apparatus. This was achieved by using expression of early
vascular smooth muscle genes, such as Acta2, as a guide. From this, we identified three
CNCC populations at mouse embryonic day, E10.5. We refer to them as the Tbx2 and Tbx3
(Tbx2/3), Isl1 and Acta2 populations, based upon distinct expression of these genes. We
suggest that the Tbx2/3 and Isl1 lineage cells may independently evolve and contribute to
smooth muscle cells of the pharyngeal arch arteries and OFT, respectively. This proposal is set
to explore the origin and fate trajectories of these three populations by dual lineage tracing, by
determining the function of genes within, and to build gene regulatory networks controlling their
development. Not only will we examine changes in NCCs but also will evaluate surrounding
SHF mesoderm cells because altering CNCCs might affect these progenitor cells as well. We
also have scRNA-seq data on the SHF mesoderm cells purified from mouse embryos. On the
other hand, it is possible that alteration of genes required in the SHF can disrupt CNCC
development. As one specific example, Tbx1, the gene for 22q11.2 deletion syndrome is
expressed in the SHF but not CNCCs, but it greatly affects their function. We will test the idea
that in Tbx1 null mutant embryos, CNCCs fail to progress from Sox10 expressing progenitors
and are not able to enter the OFT. Many of the genes to be investigated in this program are
associated with congenital heart disease in human patients. Overall, this program will help
identify molecular aspects of CNCCs and the orchestration of CNCC-SHF cell fates in
embryogenesis.

Public health relevance
NARRATIVE This project will investigate the role of cardiac neural crest cells in the mammalian heart development using mouse models and genomic technologies. We will also understand the mechanism by which these cells make cell fate choices as they form the cardiac outflow tract, aortic arch and adjoining arterial branches. The genes that we will investigate are associated with human congenital heart disease, so that we hope, in the future, to translate discoveries in mouse models to human patients.